Oklahoma Center for Microbiology Research

This Phase I CoBRE will create the Oklahoma Center for Microbiome Research (OCMR) to broadly address
key principles and questions concerning microbiome structure and function as the underpinnings of human
health and disease. Effective research requires strong administrative support and ancillary services. Thus, the
long-term goal is to transform the OCMR into an independent research center that supports and promotes
research excellence while facilitating early-stage investigators’ progress towards independence. A key to
achieving the objectives and long-term goals is the coordination of multiple research activities, career
development events and activities, interactions, mentoring, communication, networking, and reporting. The
OCMR Administrative Core will facilitate and manage these aspects of the Center. In addition to the above, the
Administrative Core will monitor the success of Research Project Leaders in achieving milestones and the
overall success of the OCMR. As such, the Administrative Core will establish and manage an Advisory
Committee to evaluate and advise the OCMR Directors and Research Project Leaders. The Administrative
Core will manage and facilitate the administration of COBRE budgets, reporting to NIH, and administering the
Pilot Project Program. The overall objective of the Administrative Core is to oversee, manage, and implement
all administrative-related activities and provide the necessary support for Research Project Leaders to succeed
and reach independent R01 status. The OCMR is well-positioned to implement the Administrative Core due to
strong leadership and management experience of the Associate Directors, Mentors with successful track
records of mentoring early-stage investigators, and institutional resources and support. The OCMR will attain
the overall objective by pursuing six Specific Aims. Specific Aim 1) Provide Administrative Management of the
Oklahoma Center for Microbiome Science Activities. Specific Aim 2) Effectively Mentor and Monitor Research
Project Leaders to Achieve Milestones Resulting in Independence. Specific Aim 3) Support Research Project
Leaders through Career Development and Guidance. Specific Aim 4) Develop a strong Pipeline of New RPLs
by Cultivating Replacement Research Project Leaders. Specific Aim 5) Establish an Effective Advisory
Committee to Oversee the COBRE. Specific Aim 6) Administer a Pilot Project Program that Supports the
Research Project Leader Pipeline.